Quantifying patient-provider communication using machine learning to assess its impact on metastatic cancer patients' outcomes

About two million persons are diagnosed with cancer every year in the US. The Effective clinical management
of cancer patients including the use of oral therapies can improve outcomes and reduce costs. However,
adherence rates to oral therapies in cancer treatment have been reported to be 20%, depending on the drug.2
Poor Patient-provider communication (PCC) is one of the barriers to adherence to oral chemotherapies in
addition to adverse drug events and lack of knowledge about adherence. Timely and effective PPC with high
levels of empathy shown by providers to address patients’ emotional concerns, wants, and needs can enhance
patients’ trust in healthcare providers, and their clinical outcomes such as adherence and emergency services
utilization. New digital health platforms such as secure messaging (SM) through patient portals can provide an
effective and timely channel of Electronic Patient-Provider Communication (EPPC). Patients with and without
cancer are increasingly using secure messaging to communicate their needs. As of May 2019, out of 1M patients
that visited Yale New-Haven Health System (YNHHS), about 436,000 patients used the patient portal resulting
in more than 2.7M messages. With the identification and quantification of EPPC in SM contents, we can measure
associations and impact on patient-centered outcomes. However, existing studies to identify EPPC patterns in
large scale SM data are limited as they focused only on patients’ messages and minimally included providers’
messages. Some studies are not scalable as they manually coded EPPC patterns for a small set of SM. We will
fill this gap using natural language processing and machine learning approaches that will utilize big SM data.
In our previous work we mapped expressions in SM into EPPC codes of communication using the Roter
Interaction Analysis System (RIAS); a method to code medical interactions and developed the Electronic Patient-
Provider Communication miner (EPPCminer) tool. It can detect three EPPC codes: information seeking and
giving, socio-emotional behavior. In this study, we will (1) refine EPPCminer to more effectively extract more
granular EPPC codes of information seeking (e.g., medication-, lab-, imaging-related), information giving of
social determinants of health (e.g., transportation, economic concerns, food), socio-emotional behavior,
partnership building, and shared decision-making. We will refine EPPCminer using SM from YNHHS and
Cleveland Clinic and evaluate generalizability using Veterans Administration (VA) data. partnership building, and
shared decision-making. We will also assess and score quality of bi-directional communication by examining
providers’ responses to patients’ requests in SM. (2) We will apply EPPCminer to SM of a cohort of patients with
different types of metastatic. We will then extract and characterize EPPC codes from 1 year worth of prospective
patients’ and providers’ SM and examine their associations with scores of patient-reported communication
assessments. (3) We will assess the impact of EPPC codes on patients’ outcomes: adherence using pharmacy
data and patient-reported adherence data, emergency room (ER) visits, and hospitalizations.

Public health relevance
Patients and healthcare providers are increasingly using the patients' portal messaging system for communication. In this study, we propose to extract different types of electronic patient-provider communication (EPPC) in the portal such as information seeking/giving and shared decision making using an innovative natural language processing and machine learning based tool called EPPCminer. We will characterize the distribution of EPPC types in messages and assess the impact of EPPC types on patients' outcomes including adherence, emergency visits and hospitalizations.